Neurocognitive and Patient-Reported Outcomes after Chimeric Antigen Receptor T-Cell Therapy: A Controlled Comparison

PROJECT SUMMARY
There is widespread excitement about chimeric antigen receptor (CAR) T-cell therapy, which causes complete
disease response in 40%-54% of adults with relapsed/refractory large B-cell lymphoma (LBCL), compared to a
response rate of 7% to chemotherapy prior to the advent of CAR T-cell therapy. For the first time, long-term
disease-free survival is possible for patients with advanced LBCL. CAR T-cell therapy causes a unique profile
of adverse events, including cytokine release syndrome (CRS) and neurologic events, which may be risk factors
for cancer-associated cognitive decline (CACD). However, little is known about neurocognition and patient-
reported outcomes (PROs; e.g., symptoms, quality of life or QOL) in CAR T-cell therapy patients. The goal of
the current study is to investigate longitudinal changes in PROs and CACD, outcomes that are highly relevant to
survivorship, in the first year after CAR T-cell therapy. We will recruit 204 LBCL patients treated with CAR T-cell
therapy and 102 age-, sex-, and education-matched individuals without cancer. Participants will be assessed at
pre-CAR T-cell therapy baseline and 3 and 12 months later to capture acute and longer-term outcomes. At each
time point, participants will complete internet-based neuropsychological testing, validated PRO questionnaires,
and 7-day smartphone-based ecological momentary assessment (EMA) of cognition and self-reported risk
factors for CACD (i.e., fatigue, depression, pain, stress). Actigraphy during EMA periods will be used to
objectively measure sleep, physical activity, and sedentary behavior as behavioral factors for QOL and CACD.
Blood will be collected and banked at each assessment for future examination of biological mechanisms (e.g.,
inflammation, accelerated cellular aging). Data will be used to address the following aims: 1) to examine baseline
differences and longitudinal changes in patient-reported outcomes and cognition in CAR T-cell therapy recipients
and controls, 2) to identify demographic, contextual, and clinical risk factors that are associated with worse
cognition in CAR T-cell therapy recipients compared to controls, and 3) to determine behavioral protective factors
associated with better cognition among CAR T-cell therapy recipients and controls. This research will be highly
impactful, providing the data needed to educate patients and their families about CAR T-cell therapy in
collaboration with the Leukemia and Lymphoma Society. Analyses focused on risk and protective factors will
provide insights into potential targets of intervention to improve QOL and CACD in this novel cancer survivor
population.

Public health relevance
PROJECT NARRATIVE Long-term survivorship is now a real possibility for patients with relapsed/refractory large B-cell lymphoma (LBCL) treated with the chimeric antigen receptor (CAR) T-cell therapy. Almost nothing is known about neurocognitive and patient-reported outcomes in patients undergoing this treatment, however. The current study will investigate longitudinal changes in these outcomes in the first year after CAR T-cell therapy compared to individuals without cancer.